Investigating the sweet side of gonorrhea to understand nutrient acquisition and sugar-based interactions with the host

The human-specific pathogen Neisseria gonorrhoeae (Ngo) causes the common sexually transmitted infection gonorrhea.
Rapid evolution of drug resistance by Ngo has led to its identification as an urgent threat and emphasizes the need to
identify an efficacious vaccine or more effective treatments. Our strategy to develop better therapeutics has focused on
conserved outer membrane transport proteins that provide critical growth supporting functions during human infection.
The outer membrane transport system (TbpA/B) that enables Ngo to employ human transferrin as an iron source is
necessary for and produced during human infections. The highly conserved zinc transporters (TdfH and TdfJ) are also
expressed in vivo. Potential drugs that target these receptors are expected to starve the bacteria of these essential
nutrients. While the human protein ligands for these transport systems are known, we unexpectedly observed that these
transporters also bind to distinct glycan moieties. Although transferrin is indeed glycosylated, the ligands for the zinc
transporters, human calprotectin and human S100A7, are not glycan modified. This unanticipated observation led us to
consider the novel concept that the outer membrane transporters serve other functions, potentially interacting with host
cell glycan-modified proteins, in addition to enabling Ngo to overcome nutritional immunity. In this application, we
propose interrogate the transporter-glycan interactions and assess whether these interactions are possibly “druggable”.
We hypothesize that these TonB-dependent transporters (TdTs) serve additional host-specific functions (e.g., support
nutrient transport or facilitate association with host cells) and that interference of TdT-glycan interactions will block Ngo
infection of host cells. These studies are significant because identification of novel compounds to interfere with either
nutrient acquisition or host cell interactions could lead to new insights into therapeutic interventions for an urgent threat
pathogen that is close to being impossible to treat with existing drugs. These studies are innovative because our
unexpected observation that the gonococcal outer membrane transporters also bind to distinct sugar residues raises the
innovative possibility that these proteins are multi-functional and serve important functions in the context of host cell
interaction, in addition to their known functions in nutrient acquisition. Other innovative aspects include the assembled
team, the complementary approaches to be utilized, and the panel of unique reagents including monoclonal antibodies
and drugs that could block critical TdT-dependent virulence functions including host cell interaction and nutrient
acquisition. The specific aims of this new proposal are as follows. Aim 1: Determine the glycans/ligands that the TdTs
interact with on host cells. Aim 2: Characterize the molecular details that define the TdT-glycan interactions. Aim 3:
Investigate the ability of antibodies and compounds to block TdT-glycan interactions and TdT functions. Overall, these
innovative studies will thoroughly interrogate the newly-recognized TdT-glycan interactions with a focus on interfering
with key virulence characteristics contributed by these well conserved outer membrane transport systems.

Public health relevance
Neisseria gonorrhoeae causes the sexually-transmitted infection, gonorrhea, for which there are dwindling treatment options and no protective vaccine. Outer membrane transporters that enable N. gonorrhoeae to utilize human metal binding proteins and overcome nutritional immunity have recognized utility as both vaccine and therapeutic targets. Our recent observations that several of these transporters also interact with specific glycan moieties and human host cells suggest that these proteins have heretofore unrecognized virulence functions, which could be exploited to prevent or treat infections with an urgent threat pathogen.